Decoding the role of naturally occurring variation in genetic and neural regulation of feeding and energy homeostasis.

Project Summary
Metabolic disorders represent one of the largest burdens in our society, with an estimated 10-30% of adults
affected by metabolic syndrome and over 11% of Americans diagnosed with diabetes. While genes that
contribute to feeding and metabolism are well described, these phenotypes are highly polygenic, and the
influence of individual alleles is shaped by genetic architecture. As such, a critical gap exists in our understanding
of how naturally occurring genetic variation shapes feeding behavior and metabolism. Evolutionary medicine
offers a powerful approach to explore how naturally occurring genetic variants impact feeding states, and the
role genetic architecture plays in shaping these alleles. Evolution provides natural experiments that shape
phenotypes in unique ways, and understanding how these phenotypes arise offers insights into how they change
across taxa, including humans.
We use the blind Mexican cavefish, Astyanax mexicanus, as a model to understand how naturally occurring
genetic variation shapes feeding and metabolism. Astyanax exists as a single species in two forms: multiple
populations of eyed, surface-dwelling fish and at least 30 populations of blind cavefish. We have shown that
cavefish are hyperphagic, perpetually insulin-resistant (akin to diabetic), and exhibit slowed metabolism. We
have also identified naturally occurring mutations in two well-known feeding receptors: melanocortin 3 (MC3R)
and melanocortin 4 (MC4R). While the role of MC4R is well understood, much less is known about MC3R, and
very little is known about how natural variations in these two receptors shape feeding. This proposal leverages
innovative approaches developed in my lab over the past seven years to address this problem from a
multidimensional perspective.
Aim 1 will explore how MC3R and MC4R work together to regulate feeding and the impact of genomic
architecture on these alleles. Aim 2 will use CRISPR-Cas9 to swap MC3R and MC4R alleles between surface
fish and cavefish, allowing us to examine the impact on feeding behavior and neural activity in feeding centers.
Aim 3 will assess brain-wide development in cavefish and explore the role of MC3R and MC4R in these
processes. This proposal is innovative in its use of CRISPR-based allele swapping and advanced brain imaging
techniques to uncover the genetic and neural mechanisms underlying these phenotypic variations. The
overarching goal is to bridge the gap between laboratory-generated mutations and the complexities of natural
genetic diversity, providing insights that could inform our understanding of obesity and metabolic disorders in
humans.

Public health relevance
Project Narrative While melanocortins are well-known for their role in modulating feeding, little is understood about how natural polymorphisms in melanocortin receptors, specifically MC3R and MC4R, shape feeding behaviors and how these receptors interact. This study leverages the blind cavefish, a unique vertebrate model with naturally occurring melanocortin mutations, combined with genetic tools like CRISPR and advanced whole-brain imaging to investigate these mechanisms. The findings will provide valuable insights into how genetic variation in this conserved pathway influences feeding, with potential applications to understanding human obesity.